Medical Scientist Training Program

The MD/PhD Program at the University of Maryland (UM) School of Medicine was established in
1982 and funded by the NIH in 2010. The mission of our Medical Scientist Training Program (MSTP)
is to train a diverse and creative cadre of physician-scientists who will become leaders in their chosen
fields of research, seek new knowledge and apply that knowledge to enhance health. Our objectives
are to: bring together the best MD-PhD students and faculty from the UM Baltimore, UM Baltimore
County, UM College Park and the NIH to provide integrated training to MD-PhD students committed
to pursuing research careers; develop and assess novel approaches to dual-degree training designed
to enhance completion rates and decrease time to degrees; recruit and retain underrepresented
minority MD-PhD students; and prepare MD-PhD students to become physician-scientists making
significant, independent contributions using their dual degree training in academia, government,
research institutes and industry consistent with NIH’s emphasis on developing the physician-scientist
workforce.
Our curriculum consists of very strong preclinical and clinical training, abbreviated graduate
didactic studies, MSTP-specific courses designed to integrate medical and scientific knowledge, and
flexible reentry from graduate school to medical school. MSTP-specific activities include: Molecules to
Medicine journal club; Graduate program orientations; Summer Research Rotations with associated
Symposium; Certificate in Methods to Enhance Research Rigor; Physician Scientist Seminars;
Clinical Case Studies and Longitudinal Clinical Clerkship during graduate school; annual MSTP
Retreat and MD/PhD endowed lecture. Our opportunities for dissertation research are extensive and
are interdisciplinary by design. Thus, our program ensures the MD/PhD students are not merely MD
students with PhD training.
During the current funding period, our MSTP has transitioned to a new Program Director (PD)
bringing a fresh perspective and new initiatives to the program. The PD, a physician-scientist with
credentials in research, education and patient care, joins an Associate Director (AD) who is an
accomplished scientist with experience running a graduate education program.
Our success during the last five years can be seen the quality and diversity of our applicant pool
and students, high publication productivity and outstanding residency placements. We plan to build
on this success by increasing the size of our overall program and continuing to develop innovative
training and mentoring strategies.

Public health relevance
This grant award will support the Medical Scientist Training Program (MSTP) at the University of Maryland School of Medicine. The mission of our MSTP is to train a diverse and creative cadre of physician-scientists who will become leaders in their chosen fields of research, develop new knowledge and translate it to enhance clinical practice. This training will serve the nation by developing physician-scientists who can accelerate the progress of biomedical research from the laboratory to the direct benefit of patients.